Neural Actions of Toluene

Project Summary
The use of volatile organic solvents as drugs of abuse is a significant and understudied health problem. These
agents, also termed abused inhalants, are voluntarily inhaled or “huffed” for their intoxicating effects and their
use is especially prevalent among children and adolescents. Volatile solvents are legal and are found in a
wide variety of household and commercial products including glues, adhesives and paint thinners. Exposure to
these compounds is associated with a variety of adverse effects ranging from reduced social and academic
performance, brain abnormalities and a sudden-death syndrome resulting from solvent-induced cardiac
arrhythmia. Although abused inhalants produce ethanol-like signs of intoxication, the sites and mechanisms of
action that underlie these effects are largely unknown. Research carried out under this NIDA funded grant
established that abused inhalants such as toluene have important and specific actions on channels implicated
in mediating the actions of a wide variety of drugs of abuse. In addition, we have shown that toluene reduces
glutamatergic EPSCs in mPFC neurons via both direct actions on ionotropic GluRs and via a novel
endocannabinoid mediated depression of signaling. A brief exposure of adolescent animals to toluene vapor
robustly enhances the AMPA/NMDA ratio in mesolimbic DA neurons while having little effect on those that
project to the prefrontal cortex. Moreover, the changes in DA neuron excitability were dependent on the output
of prefrontal cortex suggesting an important role for this region in regulating the rewarding effects of abused
inhalants. Recent results show that an acute exposure to toluene produces changes in mPFC neuron activity
that vary depending on the sub-region, layer, projection target and age at exposure while repeated exposures
induce a conditioned place preference associated with selective alterations in mPFC-NAc signaling. Reversing
these alterations with chemogenetic approaches blocked the expression of CPP. In this renewal application,
we propose three specific aims to further extend these exciting findings and examine the role of NAc neurons
in toluene reward. Aim 1 will determine how exposure to toluene vapor affects the excitability and synaptic
signaling of medium spiny neurons (MSNs) in the nucleus accumbens using both in vitro and in vivo
approaches. Studies in Aim 2 will develop and use a novel model of toluene vapor self-administration to
examine effects of voluntary toluene exposure on NAc MSN physiology. Aim 3 will test the hypothesis that
self-administration of toluene vapor is blocked by manipulating the activity of NAc MSNs and their specific
excitatory inputs from mPFC sub-regions. Overall, the results from these studies will fill an important gap in
our knowledge regarding the actions of abused inhalants on the addiction neurocircuitry.

Public health relevance
Project Narrative Abused inhalants are an important class of drugs of abuse that have received relatively little attention with respect to their sites and mechanisms of action. Research to be carried out in this proposal will provide a detailed analysis of the effects of abused inhalants on neurons and neural circuits involved in addiction.